Development of optoelectronically active nerve adhesive for accelerating peripheral nerve repair

Project Summary
Peripheral nerve (PN) injury represents a major public health problem that leads to functional impairment and
permanent disability. Microsurgical suturing, standard approach for long-gap PN repair, is a time-consuming
procedure and causes nerve damage, inflammatory foreign body reactions, and scar formation, which delay
the PN regeneration. As potential alternatives, tissue adhesives have been developed to reduce operation time
and avoid secondary damages. However, current commercially available tissue adhesives, like fibrin glue and
others, are far from ideal, considering cytotoxicity, tissue compression due to extensive swelling, and poor
mechanical properties. We have developed a novel dual network nerve adhesive (NA) consisting of catechol
modified hyaluronic acid and decellularized peripheral nerve matrix hydrogels. Our NAs illustrated significantly
higher adhesion strength and adhesion force, compared to catechol modified HA only and commercial fibrin
glue. The NAs supported Schwann cell proliferation and improved PN repair after transection injury comparing
to fibrin glue. However, both sensory and motor functions were still incompletely recovered after microsuturing
or NA repair in the transected and long-gap nerve injury models. In this proposal, we will further incorporate
innovative optoelectronic biomaterials (i.e., Si based μ-solar cells) within the NA to develop next generation of
optoelectronically active NAs (optoENAs) for long-gap PN injury regeneration. The Si based μ-solar cells are in
micrometer size, biocompatible, biodegradable, and photo-stimulable to generate sufficient electrical output.
The specific aims of the studies are (1) to develop functional optoENA and determine how the size and
concentration of μ-solar cells affect NA properties and PN related cell behaviors; and (2) to determine whether
and how optoENAs expedite surgical procedures, facilitate autograft implantation, and promote long-gap PN
repair in a rat model. This proposal will develop a novel and clinically applicable tissue adhesive with enhanced
adhesive performance and optoelectronic properties for improving healing and regeneration of long-gap PN
injury.

Public health relevance
Project Narrative Peripheral injury represents a major public health problem that often leads to significant functional impairment and permanent disability. Following long-gap peripheral nerve injury and standard repair, the recovery is rarely complete, usually resulting in sensory loss, impaired motor functions, and chronic pain. This proposal will develop a novel dual network nerve adhesive with high adhesive strength and optoelectronic properties to replace suturing process and improve long-gap peripheral nerve regeneration in a rat model.